Ethical Multimodal AI Development for Obesity, Diabetes and Digestive Disease

Abstract
Multimodal AI (MAI) has enormous potential to provide useful tools for AI-integrated healthcare.
To realize this potential, there is a need to address difficult problems at multiple stages of MAI
model development: 1) identify and prepare clinically-relevant, inclusive datasets to assure
generalizability, 2) develop ethical MAI models integrating multimodal data, 3) develop MAI
models that account for missing data, longitudinal data, and distribution shifts, 4) co-design
models with stakeholders and 5) develop green, scalable compute infrastructure and models that
can be deployed in practice. We will address these challenges in the following aims. In Aim 1, we
will develop self-supervised MAI foundation models for multimodal and longitudinal input/output
data. Data, such as images, videos, electronic health record data (structured/unstructured text),
biospecimen and genetic data will be encoded into a shared representation space. Our novel
model will include a virtual ethics critic to supervise model expressiveness along ethical
guidelines. The data source is the Penn Medicine BioBank (PMBB), which has enrolled 250k+
patients. In Aim 2, we will use an iterative and concurrent mixed methods co-design evaluation,
including a multi-stakeholder committee and interviews with providers and patients informed by a
conceptual framework for the ethical design, use and governance of AI in healthcare to inform
model construction in Aim 1. In Aim 3, the general-purpose model will be fine-tuned for liver
disease, digestive disease and frailty applications. The deliverable will be open-source MAI
models, employing FAIR principles and informed by ethical co-design to provide clinical decision
support.

Public health relevance
This project will support public health by developing ethical multimodal artificial intelligence systems that can help clinicians interpret complex medical imaging, clinical text, and related health data for conditions including obesity, diabetes, digestive disease, cognitive impairment, and abdominal disease. By incorporating patient, provider, and stakeholder perspectives into the design and evaluation of these systems, the project aims to improve the safety, fairness, transparency, and clinical relevance of AI-assisted healthcare.